Data Analysis Core

PROJECT SUMMARY – Data Analysis Core. The VU-BIOMIC data analysis core (DAC) is tasked with
automation of the reconstruction and subsequent analysis of the acquired multimodal eye and pancreas tissue
imaging data. This is translated into four specific aims: (i) modality-specific data processing; (ii) data analysis
pipeline development for 2-D and 3-D molecular tissue mapping; (iii) map construction for establishing 3-D
molecular organization and function; and (iv) consortium coordination. In Aim 1, we will develop methods for
preparing acquired measurement data for subsequent spatial integration, analysis, and content mining, and to
remove any non-biological variation from the measurements prior to integration. In Aim 2, the DAC provides
rapid cues for data quality assessment and ongoing multimodal analysis as new data is integrated into the
atlases. Pre-analytically, we will develop data-derived sample inclusion criteria based on LC-MS/MS
measurements, combined with gold standard histopathology, to capture what is “normal” tissue. To enable data
mining of the massive 3-D multimodal spatially resolved datasets, accurate registration of multiple 2-D datasets
into 3-D volumes will be essential. We will build a high-resolution mono-modal 3-D scaffold, using pre-
measurement autofluorescence microscopy taken from every single tissue section. Furthermore, the 3-D data
and analysis outputs, reconstructed from serial sections, will be spatially linked (by means of 3-D-to-3-D
registration models) to the organ-specific in vivo and ex vivo 3-D scans to relate the acquired spectral data to
more commonly encountered medical imaging modalities. Data-driven image fusion will enable the empirical
discovery of potential correlative, anti-correlative, multivariate linear, and nonlinear relationships between
observations in the different modalities, and also provide a framework for estimating to higher spatial resolutions
as well as for out-of-sample prediction from one modality to another. The DAC will perform temporally resolved
analysis of the data to find how molecular content changes with patient age. In Aim 3, the map construction
phase, we will bring the third dimension to the varied data types that are measured and annotated. Data-driven
image fusion will be used to advance the 3-D maps beyond what can be gleaned from one technology alone,
including the application of IMS-AF-fusion-driven out-of-sample prediction. This will enable prediction of IMS
observations at cutting depths where no IMS is measured. This will effectively provide predictive up-sampling of
the 3-D tissue maps along the z-axis, building finer resolution 3-D volumes than would be possible with IMS
alone. In Aim 4, we will develop specifications for the open file formats used in this work, multilingual parsers to
ease access, and a URL-based Restful API to make (authorized) data exchange easy and accessible. We will
work with the consortium to build common coordinate atlases based on in vivo images and continue the work of
the currently funded project in specifying and developing easily disseminated file formats.